Training in Musculoskeletal Science

Abstract
The Rochester Musculoskeletal (ROCMSK) Training Program, administered by the University of Rochester's
Center for Musculoskeletal Research (CMSR), is committed to developing future generations of innovative,
responsible leaders in musculoskeletal science. Building on a legacy of excellence and over $28M in current
funding of 31 diverse and interdisciplinary faculty mentors, the ROCMSK's Training Program renewal proposal
offers a dynamic training experience for a diverse cohort of five pre-doctoral trainees. Through mentorship,
individualized development plans, and access to extensive institutional resources like myHub and UR BEST,
trainees will receive comprehensive career guidance and support. The program's emphasis on scientific
communication, wellness, and a supportive academic environment will cultivate independent thinkers and
collaborative problem solvers. The program's commitment to translational research will be enhanced through
innovative clinical shadowing experiences and networking travel sabbaticals, providing trainees with invaluable
insights into the real-world impact of their research findings. ROCMSK aims to: 1) Provide a rigorous
foundation in trans-disciplinary musculoskeletal research, emphasizing cutting-edge methodologies, ethical
conduct, and data-driven discovery. Trainees will engage in hands-on research rotations and
thesis/dissertation projects under the mentorship of accomplished faculty. 2) Nurture critical thinking,
independence, and a deep understanding of musculoskeletal health. Trainees will benefit from clinical
shadowing, networking opportunities, and collaborations with academic and industry partners. 3) Leverage
institutional resources to enhance professional development, collaboration, and leadership. Individualized
development plans (IDPs), mentorship, career workshops, and institutional resources like myHub and UR
BEST will support trainees' growth. 4) Empower trainees to excel in scientific communication. Structured
training, including student-led grant-writing groups and mock NIH study sections, will prepare trainees for
successful research careers. 5) Promote trainee wellness and a supportive academic environment.
Collaboration with the institutional Learner Life and Wellness initiative will ensure holistic well-being, fostering
resilience and collaboration. 6) Rigorously evaluate program effectiveness. Annual assessments through focus
groups, interviews, and surveys, facilitated by the Center for Professional Development and Education Reform,
will drive continuous improvement. With its national reputation, extensive collaborations, and structured training
program, ROCMSK is well-positioned to meet the growing demand for skilled musculoskeletal scientists. The
program's commitment to diversity, inclusion, and holistic trainee development ensures a competitive and
supportive environment for future leaders in the field.

Public health relevance
Narrative The Rochester Musculoskeletal (ROCMSK) Training Program is training the next generation of experts in bone, muscle, and joint health. This program gives Ph.D. students hands-on research experience, career guidance, and opportunities to collaborate with top scientists in the field. The goal is to develop well-rounded researchers who can make new discoveries and improve treatments for musculoskeletal conditions.